Mechanisms of early axonal pathfinding in the olfactory system of larval zebrafish

Abstract
In the olfactory system precise connections create a functional topographic map that translates odorant
experience into ordered patterns of odorant-specific neural activity. This map is established early in development.
Olfactory Sensory Neurons (OSNs) stochastically choose to mono-allelically express one Odorant Receptor
(OR), which belong to the G-Protein Coupled Receptor (GPCR) family, from a large gene repertoire. Each OSN
projects a single axon from the Olfactory Epithelium (OE) to the Olfactory Bulb (OB). Axons of OSNs first target
larger identifiable neuropils called protoglomeruli. In zebrafish, our lab has found that the protoglomerulus an
OSN axon targets correlates with the family or homology clade of its chosen OR. OSNs expressing ORs from
different homology clades target different protoglomeruli. Subsequent to this initial protoglomerular targeting,
the axons of OSNs expressing the same OR ultimately coalesce into smaller, distinct, and reproducible neuropil
regions known as glomeruli. Thus, the target location of each axon on the OB is coordinated with its chosen OR.
Previous research has shown that an OSN’s chosen OR and OR-driven neural activity are important for
glomerular segregation. However, it is not known how clade-specific protoglomerular targeting and OR-specific
glomerular segregation are achieved. Previous studies performed in the mouse may have conflated initial
targeting processes with glomerular segregation due to the relative inaccessibility of early developmental stages.
The foundational research in olfactory development utilized static imaging after development was complete,
often leading to developmental processes being inferred rather than investigated. We believe protoglomerular
targeting is determined by the coordinated expression of the OR locus and axon guidance loci, rather than OR
protein function. We have shown through single-cell RNA sequencing that OSNs expressing ORs within the
same homology clade also express similar transcription factors and axon-guidance-related factors. Further,
OSNs expressing closely related ORs target nearby glomeruli. Thus, I hypothesize that regulators controlling
OR choice in OSNs also regulate axonal guidance receptor expression, while OR-specific neural activity
regulates the subsequent segregation of OR-specific glomeruli. Utilizing a recombinase-mediated cassette
exchange approach, my proposed experiments will disambiguate the relative contributions of OR identity and
OR-driven neural activity to protoglomerular and glomerular targeting.

Public health relevance
Project Narrative The olfactory system is one of a handful of neural systems composed of continually regenerating neurons in mature humans and proper targeting of olfactory sensory neurons (OSNs) to highly specific locations on the olfactory bulb is essential to odorant detection and recognition. Individuals with Parkinson’s Disease or Alzheimer’s Disease commonly complain of anosmia, the loss of smell. The objective of this project is to decipher how OSNs connect with high precision to the OB during embryonic development, as understanding these fundamental developmental processes should provide clues relevant to preventing or repairing anosmia in later life.